Preventing the Calcium Channel Blocker – Lower Extremity Edema – Loop Diuretic Prescribing Cascade in Older Adults

PROJECT SUMMARY. Prescribing cascades (PCs), in which drug-induced adverse events (AEs) result in
additional treatment rather than deprescribing or dose reduction of the offending agent, are a central problem
in geriatric polypharmacy. Unlike other drug combinations that should be avoided, such as drug-drug
interactions, there is currently no process that alerts providers of PCs. To prevent or deprescribe PCs,
providers must evaluate complex medication regimens and multiple chronic conditions that may contribute to
drug-induced AEs. Appropriate design and implementation of clinical decision support (CDS) offers a
promising approach to enhance timely detection of PCs. In this work, I will use a research framework that
evaluates PCs and develops CDS tools for detection in clinical practice, using the example of a presumably
common and problematic PC: calcium channel blocker-associated lower extremity edema leading to the
prescribing of a loop diuretic (CCBLEELoop). My specific aims include (Aim 1) estimating the incidence
and evaluating which populations are at highest risk of CCBLEELoop PC, (Aim 2) quantifying
excess AEs, healthcare utilization, and costs associated with the CCBLEELoop PC, and (Aim 3)
developing and validating a CCBLEELoop PC algorithm for use in CDS to prospectively identify
individuals with the PC. This NIA K08 proposal will lay the foundation, both in training and research output,
for building an independent research program that combats polypharmacy in older adults, with particular focus
on minimizing unnecessary medication use. My extensive experience in geriatric clinical pharmacy and my role
as the Assistant Director of Pharmacy Services with University of Florida (UF) Health Physicians, the faculty
practice of UF Health, will ensure deep clinical context and relevance of this work. My initial exposure to
observational research methods and experience with Medicare data during my doctoral training will be
enhanced through this K award in three distinct areas relevant to the proposed work: (1)
pharmacoepidemiologic methods including the use of advanced longitudinal analyses to make causal
inferences on drug effects, (2) development and validation of CDS, and (3) implementation science. UF Health
is the largest fully-integrated academic health center in the Southeast and its excellent big data infrastructure
provides an ideal environment for achieving the proposed objectives and my long-term goals. Dr. Winterstein
will guide my training in pharmacoepidemiology and lead a multidisciplinary mentorship team composed of
experts in CDS development and implementation and economic evaluation of drug effects (Dr. Malone), aging
(Dr. Manini), biostatistics (Dr. Brumback), clinical management of hypertension (Dr. Pepine), clinical geriatrics
(Dr. Solberg), and alert development, evaluation, and implementation (Dr. Staley). The integrated mentored
research experience and training will allow me to compete for R01 funding focused on CDS implementation
and build an independent research program that combats polypharmacy in older adults.

Public health relevance
PROJECT NARRATIVE Prescribing cascades (PCs), in which drug-induced adverse events (AEs) result in additional treatment rather than deprescribing or dose reduction of the offending agent, are common in older adults with consequences ranging from increased treatment burden to adverse effects that can ignite a rapid downward spiral resulting in disability or death. Using pharmacoepidemiologic methods, I will assess incidence and the downstream consequences of the calcium channel blocker-associated lower extremity edema leading to the prescribing of a loop diuretic PC and develop and validate an algorithm for use in clinical decision support that can be tested and integrated into clinical practice in order to prevent and mitigate the PC. This project will lay the framework for quality improvement processes aimed at enhancing medication safety and quality prescribing while reducing costs by combating polypharmacy in older adults.